Impact of intra-host population structure on influenza virus antigenic evolution

SUMMARY
At the global population level, seasonal influenza A virus (IAV) evolution is characterized by repeated selective
sweeps in which novel antigenic variants that escape antibody responses replace previously circulating strains.
Despite this clear pattern at a population level, selection of antigenic variants is not typically seen within
individuals with acute IAV infection. This apparent disconnect between evolutionary processes at population and
within-host scales contributes to the challenge of predicting evolutionary outcomes. The processes that impede
IAV selection within the host, and their potency, have not been examined systematically. To address this
knowledge gap, we will test the central hypothesis that the genetic structure of within-host viral populations plays
a major role in defining the likelihood that a beneficial mutation becomes fixed. In particular, we hypothesize that
the fate of a highly fit variant virus is shaped by its initial prevalence in the inoculum (quantitative structure), the
timing with which it arises de novo (temporal structure), its location within the infected tissue (spatial structure)
and the presence or absence of competing variants (clonal interference). In turn, we predict that onward
transmission of a beneficial variant will rely on a combination of these factors and the stringency of the
transmission bottleneck. We furthermore propose that the severity of the bottleneck is modulated by pre-existing
immunity in the host. To test these hypotheses, we will monitor the dynamics of mixed viral populations
containing a seasonal IAV and one or two HA antigenic variants thereof within individual guinea pigs and between
transmission partners. Partial immunity will be induced with vaccination to yield a model in which the antigenic
variants have a selective advantage. Distinct sequence barcodes will be included in the HA and NA genes of
each virus to allow sensitive detection of genetic bottlenecks. Tracking barcodes in both HA and NA will allow
genetic linkage to be assessed. The wild type and antigenic variant viruses will be combined in vivo with various
quantitative, temporal and spatial structures and then barcode dynamics will be monitored by sequencing. With
this approach, we will perform a systematic evaluation of the consequences of population genetic structure for
viral evolutionary dynamics. This well-controlled and systematic approach will allow identification of processes
that impede selection within and between individual hosts, providing much needed insight into the forces shaping
IAV evolution where it begins.

Public health relevance
PROJECT NARRATIVE Viral evolution presents a major challenge to vaccination programs designed to limit the public health and economic impacts of seasonal influenza epidemics. Our research seeks to address this challenge by elucidating the mechanisms that shape influenza A virus evolution.